NEUROLOGICAL COMPLICATIONS OF SICKLE CELL DISEASE

Sickle Cell disease predisposes the patient to serious neurological complications. The most debilitating complications include stroke and chronic encephalopathy. The aims of this study are directed at a more complete understanding of the scope of these neurological complications, and the factors that contribute to their development.